Pathologically Interpretable Computational Imaging Predictor for Response to Total Neoadjuvant Treatment in Rectal Cancers

PROJECT SUMMARY: Of the estimated 46,220 patients who will be newly diagnosed with rectal cancer in 2024,
patients with locally advanced rectal cancer will undergo total neoadjuvant therapy (TNT) to reduce tumor burden
followed by standard-of-care surgical excision of the rectum. Up to 50% of these patients exhibit near complete
clinic response (CR, i.e., very few/no tumor cells) on the post-surgical specimen. These patients are therefore
ideal candidates for a “watch-and-wait” (W&W) approach, a treatment regimen that replaces unnecessary morbid
surgery with intensive surveillance; which results in a significantly improved quality of life while maintaining
current disease-free survival rates. However, due to a lack of consistent clinical criteria and variable evaluation
of routinely acquired MRIs, the 50% of rectal cancer patients that present with CR cannot be reliably
distinguished from non-CR patients. Thus, the key clinical challenge in rectal cancers is accurately and non-
invasively identifying patients that exhibit CR after TNT and are candidates for W&W.
TNT is known to induce desmoplastic stromal reactions in the tumoral and peritumoral environments due to
treatment effects and tumor regression. These pathologic tissue changes are very subtle and difficult to
objectively discern on routine MRI. Deep learning (DL), a form of artificial intelligence that utilizes large neural
networks to extract textural, morphological, and other attributes, could enable more quantitative characterization
of treatment response on imaging. Applying DL approaches for accurate identification of CR in rectal cancers
while also maintaining clinical interpretability would require (a) ensuring the DL model uses specialized image
filters to capture surrogates of subtle desmoplastic reactions to TNT on routine MRI, (b) biological validation of
DL predictions against underlying histology via spatial fusion of MRI and digitized pathology specimens, and (c)
rigorous external evaluation of DL performance on a clinical trial cohort of patients who were administered TNT.
In this proposal, I will engineer and validate a novel DL framework that leverages wavelet texture filters, called
RadWaveNet, to comprehensively quantify TNT response of rectal cancers on MRI. Aim 1 will first develop and
optimize RadWaveNet on pre- and post-TNT MRI scans across multiple acquisition planes from a diverse patient
population to ensure equity in performance in race- and age-based subgroups. Aim 2a will focus on biologically
validating that RadWaveNet signatures captured imaging surrogates of tissue responses associated with CR via
spatial co-registration of the post-surgical pathology and pre-operative imaging. In Aim 2b, RadWaveNet will
undergo rigorous clinical validation with comparison against gold-standard pathologic response markers for
rectal cancer datasets retrospectively curated from the NCT02688712 clinical trial. My project will build upon my
promising preliminary results for developing DL models to characterize the rectal lesion environment on MRI, as
well as constructing wavelet DL models for predicting response to neoadjuvant chemoradiation; towards a
clinically reliable, non-invasive tool for personalizing treatment in rectal cancers.

Public health relevance
PROJECT NARRATIVE: This F31 proposal aims to engineer and rigorously validate novel computational imaging tools for accurate identification and assessment of rectal cancer patients that exhibit near complete clinical response to total neoadjuvant therapy (TNT) via routine MRI. In the long-term, these novel tools for non- invasively assessing TNT response on MRI could enable near complete responders to be placed on personalized, organ-preserving treatment regimens, avoiding unnecessary and highly morbid surgery.